Reducing Health Disparities Through Informatics

PROJECT SUMMARY
Columbia University School of Nursing has been the leader in preparing nurse scientists to conduct
interdisciplinary informatics research for nearly two decades through the Reducing Health Disparities Through
Informatics (RHeaDI) Pre and Postdoctoral Training Program (T32NR007969) and related funding sources.
Moreover, RHeaDI leaders, preceptors, and trainees have conducted interdisciplinary informatics research that
has advanced nursing science and health equity. RHeaDI aims and training activities in this competitive
renewal build upon the substantial achievements of its 19 years of funding and are well-aligned with the
National Institute of Nursing Research (NINR) commitment to supporting nursing science that focuses on (a)
dismantling structures that perpetuate racism and impede health equity; (b) developing and implementing
interventions that address social determinants across the lifespan; and (c) developing and advancing
innovative holistic and precision health across the lifespan. Building upon RHeaDI’s unique and historic
strengths in informatics and data science and the focus on precision health approaches in the last competitive
renewal, the competitive renewal focuses on overcoming structural obstacles to health for everyone ---
regardless of race, ethnicity, gender, or income. Given our success in recruiting a diverse cadre of nurses for
RHeaDI and the program outcomes, we are requesting 4 predoctoral and 4 postdoctoral positions. The specific
aims of RHeaDI for the competitive renewal for Years 21-25 are to: 1) Maintain an administrative structure to
support interdisciplinary research training for nurses focused on the use of informatics and data science
approaches to advance health equity, holistic and precision health, and facilitate evidence-based practice in
underserved populations; 2) Recruit and train a qualified diverse cadre of nurses from different backgrounds,
cultures, experiences, and perspectives to conduct interdisciplinary research focused on using informatics and
data science approaches to advance health equity, holistic and precision health, and facilitate evidence-based
practice in underserved populations. 3) Enhance the knowledge and skills of predoctoral and postdoctoral
nurse trainees in the integration of theories and methods from informatics, data science, and minority health
and health disparities research to advance health equity, holistic and precision health, and facilitate evidence-
based practice in underserved populations; and 4) Evaluate the training program structures, processes, and
outcomes on an ongoing and annual basis. The need for nurse scientists trained to achieve the focus of the
RHeaDI aims is greater than ever and Columbia University School of Nursing with its exceptional resources is
uniquely qualified to lead this innovative training program.

Public health relevance
PROJECT NARRATIVE The Reducing Health Disparities Through Informatics (RHeaDI) research training program will prepare nurse scientists with knowledge and skills to conduct interdisciplinary informatics and data science research to advance health equity. This competitive renewal will focus on (a) dismantling structures that perpetuate racism and impede health equity; (b) developing and implementing interventions that address social determinants across the lifespan; and (c) developing and advancing innovative holistic and precision health across the lifespan.